How Distinct Age-Associated B Cell Subsets Can Protect the Aged from Influenza

ABSTRACT: How Distinct Age-Associated B Cell Subsets Can Protect the Aged from Influenza. With age,
the generation of T follicular helpers from naive CD4 T cells, and of germinal center B cells from follicular B cells,
both of which are essential for the generation of high affinity antibody (Ab), become highly compromised. Most
current vaccines for influenza in the elderly are ineffective at inducing these critical responses. Thus, the elderly,
though protected by Ab already in place for pathogens encountered earlier in life, are highly susceptible to new
strains of virus (e.g. new yearly variants of influenza) and newly emerged pathogens (e.g. pandemic influenzas,
COVID-19). In aged mice, we noted the generation of an unusual population of Ab-secreting B cells in response
to live influenza infection. We found they are derived from stimulation of recently described "age-associated B
cells" (ABC) rather than conventional naïve follicular B cells. In aged mice influenza-induced ABC (iABC)
responses are generated independently of CD4 T cell help, but are strictly depend on stimulation by pathogen-
associated "danger" signals. Notably, the ABC are the predominant naïve B cells that respond to influenza
infection in aged mice. We find only the IgD ABC subset of naïve ABC, respond, and that IgD ABC include two
subsets, T-bet+/CD11c+ and T-bet-/CD11c-. Here we will determine the potential of each of these to respond to
infection and generate Ab-secreting cells (AbSC), B cell memory and long-lived Ab-secreting cells in the lung
and nasal tissues as well as the spleen, lymph node and bone marrow and define what signals from the influenza
infection are needed. We will determine the contribution of the T-bet and non-T-bet responses to protection from
reinfection. We will compare the ability of live influenza virus, whole inactivated virus and mRNA-LNP vaccine to
generate ABC-derived responses and induce protective immunity, and test if adding infection-associated signals
improves this. These results will give us new insights into this novel age-associated immune pathway and should
provide new indications of how vaccines can be improved to provide more robust protection to the elderly who
currently are highly vulnerable.

Public health relevance
NARRATIVE Recently we found that a unique age-associate B cell population (ABC) population includes a naive IgD B cell population that after influenza infection generates a unique extrafollicular effector B cell response, and that makes the predominant Ab response to influenza in the aged. The naïve IgD ABC contains both T-bet-expressing (about 1/4th) and non-T-bet expressing cells ABC, and during response we find a similar distribution, suggesting two sub-lineages of ABC. We will define the requirements for inducing these subsets of ABC to become effectors and memory and will determine ways to augment vaccines to provide each signal needed to provide protection.